NUCATS CTSA K12 Program at Northwestern University

Leveraging our experience as a KL2 program, we submit this Northwestern University Clinical and
Translational Sciences Institute (NUCATS) K12 application in conjunction with the NUCATS UM1, T32, and
R25 applications. Through a needs assessment, brainstorming sessions, and interviews, we identified key
challenges – translational science (TS) competency training that is a foundation for life-long learning and high
impact research; advancing a culture of inclusive excellence – and solutions, training innovations which we
have started to implement in our KL2 and will expand in the proposed K12. Our overarching goal is to train and
nurture diverse clinical and translational scientists to be resilient leaders of high-functioning, interdisciplinary
teams, leaders who are well positioned to tackle translational roadblocks and procure external funding, and
who employ implementation science (IS) principles and partner with affected/interested groups and end-users.
We propose the following specific aims: Aim 1) Provide K12 structure including communication, advisory
support, oversight, and integration with the UM1 and T32 and other institutional training programs, to optimize
effectiveness and efficiency of operations; Aim 2) Model interdisciplinary collaboration through diverse and
dedicated Program Faculty to help fill gaps in Scholar mentoring and require all faculty to complete 1 of 2
offered options of mentor training; Aim 3) Promote diversity of applicants through (a) outreach, including to, as
stated in NIH NOT-OD-20-031, “underrepresented populations in the U.S. biomedical, clinical, behavioral, and
social sciences research enterprise” based on race, ethnicity, disadvantaged background, and disability, and
(b) K12 application support; Aim 4) Build an ESI Academy, an inclusive near-peer community of K12 Scholars
and any K- or R-aspirer, including ESI Academy Socials and a seminar series with core and elective content
for the Scholars; Aim 5) Personalize Scholar training using (a) a baseline assessment of TS and translational
research competencies, (b) identification of the desired mastery level for each competency, and (c) an
individualized training roadmap, using a novel tool – which we call COMPASS (Competency Assessment and
Pathway Development) – to prioritize and monitor proficiency development; Aim 6) Provide enhanced
approaches such as: (a) an active learner model with Scholars as PI of their training roadmap, (b) training that
is non-siloed, i.e., delivered by cross-disciplinary mentors, (c) hybrid and online delivery, archived for efficient
and timely Scholar use, and (d) leadership training including seminars and coaching; Aim 7) Evaluate the K12
Program using continuous improvement evaluation cycles to: (a) help to ensure that we are at the forefront of
best practices and to position us to innovate, and (b) assess outcomes, using a priori designated metrics; Aim
8) Disseminate best practices and knowledge gains to our institution, the other Chicagoland CTSAs, the larger
Chicagoland community, and the national CTSA consortium, including through a digital repository open to all
and discoverable, hosted by NUCATS and the Galter Health Sciences Library.

Public health relevance
Key challenges to the sustenance of a workforce that conducts research which will impact individual and community health include inadequate training (a) in translational science, which is focused on understanding the scientific and operational principles underlying each step of the translational process, and to acquire the unique attributes of a translational scientist, and (b) to advance a culture of inclusive excellence that promotes problem solving and innovation by maximizing contributions from different perspectives and lived experiences. Our overarching goal is to train and nurture diverse clinical and translational scientists to be resilient leaders of high-functioning, interdisciplinary teams, leaders who are well positioned to tackle translational roadblocks, and who employ implementation science principles and partner with communities, affected/interested groups, and end-users.